Pore Formation by Cholesterol Dependent Cytolysins

Our work over the course of nearly 25 years of this grant have revealed insights onto the pore-forming mechanism
of the cholesterol-dependent cytolysins (CDCs), which have laid the foundations to understand the basis by which
this large class of toxins make the transition from soluble monomers to large oligomeric membrane-embedded
pore complexes. In the next 5 years of the merit award we propose to address three specific aims, which will
continue our work on the CDCs but will also open up new major fields of research in related areas. In the first aim
we will address outstanding issues in the mechanism of the CDC pore-forming mechanism. The first of these is to
understand how the β-barrel pore assembles and inserts into the membrane bilayer. This is a question that applies
to all β-barrel pore-forming proteins but is fraught with complicating thermodynamic factors. Using our previous
discoveries of the transition state barriers to pore formation and the ability to change the nature of the β-hairpins
we will determine the mechanism of β-barrel assembly and membrane insertion. These studies will also address a
contentious issue in the CDC-mechanism, which is whether incomplete oligomers (rather than complete rings)
can insert a partial β-barrel into the membrane. In this aim we will also reassess the basis by which the listeriolysin
0 pH sensor functions, as we have recent published data and preliminary studies, which suggest that our original
hypothesis made in 1995 is not the mechanism of pH sensing. In the second aim we plan to pursue the study of
the CDC-like (CDCL) proteins that we have determined to be ancient relatives of the CDCs (perhaps the
forerunners of the CDCs), the genes for which are widespread in numerous bacterial species (>300 so far) from at
least 6 different phyla, as well as a few species of diatoms and fungi. Our primary goals are to (1) understand the
pore-forming mechanism of these toxins, as some preliminary data suggest there are some fundamental
differences with the CDCs, and (2) to identify the prokaryotic and/or eukaryotic targets of several of these proteins
isolated from species from the oral and intestinal human microbiomes and from terrestrial environments, as none
of the CDCL binding domains exhibit any similarity to the canonical binding domain of the CDCs. In the third aim
we plan to study the mechanism of bacterial killing by a novel class of anti-bacterial toxins that are produced by a
few species of the Provotella and Bacteroides found in the oral and intestinal microbiome of humans. Our
preliminary studies suggest that they are proteolytically-activated toxins that form higher order complexes
(possibly pore-forming toxins), which target various species of bacteria. Our preliminary studies suggest that they
are a unique class of antibacterial toxin, as there are no known class of prokaryotic or eukaryotic toxins that exhibit
any similarity to the primary structure of these toxins.

Public health relevance
RELEVANCE (See instructions): Our proposed work continues to be fundamentally basic research on the cholesterol-dependent cytolysins but which often leads to translational applications (i.e., vaccines) and supports the efforts in the field of pathogenesis where these toxins contribute to disease. These studies have led us to the discovery of a large class of ancient CDC relatives that have spread throughout the Bacteria kingdom and are present in many major species of the human microbiome. Finally, these studies will reveal the molecular mechanism of a unique class of anti-bacterial toxins, which could potentially be used in therapies for infections.